Core--Biostatistics and Data Management

The goal of the research projects in this Program Project application is to elucidate the mechanisms of immune regulation following allogeneic hematopoietic stem cell transplantation (HSCT). Important to the success of this project is the biostatistical collaboration with individuals in each of the 3 projects and the 2 other Cores. The purpose of the Biostatistics and Data Management Core (Core B) is to provide the following services that will be utilized by all of the research projects included in this Program Project. Specific Aim 1: To provide biostatistical collaboration for clinical research protocols and laboratory and animal research studies. Specific Aim 2: To provide clinical data management for collection of individual patient information, data management support, forms design, and quality control for clinical protocols. Specific Aim 3: To provide a central mechanism for specimen collection, identification and tracking between the projects.